The Colorado Building Interdisciplinary Research Careers in Women's Health Program Administrative Supplement

Project Summary
The NIH Office of Research on Women's Health (ORWH) has received a special FY22 Congressional
Appropriation of $4M to fund additional Building Interdisciplinary Research Careers in Women's Health NIH
K12 (BIRCWH) Scholars at existing sites with the goal of increasing the diversity of the Scholars and research
areas supported by the program. The Colorado BIRCWH, given its strong focus on increasing diversity, is
requesting funding for a 4th BIRCWH Scholar via the resulting Administrative Supplement. If funded, our 4th
Scholar will be Dr. Maigen Bethea, who is a talented early career Black woman scientist. Dr. Bethea's long-
term academic goal is to combine her previous and current training to become an expert on the impact of sex
on the role of the gut-brain-pancreas axis in regulating glucose metabolism. In our application, we briefly
describe the personnel, resources, strategy and goals of the Colorado BIRCWH program m, all of which are
applicable to her (see parent grant application for all details). If Dr. Bethea is funded for BIRCWH, her primary
mentor will be a highly accomplished, well-funded scientist who is also from a diverse background, Dr. Darleen
Sandoval. The BIRCWH leadership along with Dr. Sandoval and co-mentor, Dr. Jane Reusch, will work with
Dr. Bethea in the rich academic environment of CU-AMC. We will help Dr. Bethea form her interdisciplinary
Scientific Advisory Committee (SAC). As with other BIRCWH Scholars, her SAC and BIRCWH leadership will
meet twice yearly as a group along with her. She will participate in monthly trainings using an evidence-based
curriculum focused on developing academic and career development skills. She will also participate in all of the
other BIRCWH educational activities. Biostatistical support will be readily available and Dr. Bethea will be able
to work with a medical editor/writer. Our Internal Program Advisory Committee will continue to evaluate
program operations and progress; our External Program Advisory Committee will continue to provide an
outsider's overview of the BIRCWH to assure that we stay abreast of national trends in women's health and
sex differences research. Importantly, the recently refunded Colorado BIRCWH parent grant application
contains detailed and complete information on all aspects of the program. Over the past 15 years, we have had
21 Scholars in the program, 18 of whom have remained in academic medicine and 15 have received external
funding (the 3 of 18 not yet funded are current Scholars early in their BIRCWH term). Collectively these
Scholars have published over 600 publications since their time in the BIRCWH program (not including
abstracts). The excellent institutional support for the Colorado BIRCWH, with strong focus on women's health
and sex differences, will continue to fuel the growth of this important program which aims to develop
successful, independent interdisciplinary scientists in women's health and sex differences research and
thereby improve the health of women.

Public health relevance
Project Narrative The Colorado Building Interdisciplinary Research Careers in Women's Health NIH K12 program, given its strong focus on increasing diversity, is requesting funding for a 4th BIRCWH Scholar via an Administrative Supplement from the Office of Research on Women's Health. If funded, our 4th Scholar will be Dr. Maigen Bethea, who is a talented early career Black woman scientist and whose long-term academic goal is to combine her previous and current training to become an expert on the impact of sex on the role of the gut- brain-pancreas axis in regulating glucose metabolism. By equipping early career scientists, such as Dr. Bethea, with interdisciplinary training and excellent mentoring, to be the research leaders of tomorrow, we have every expectation that our scientists will lead the way to tangible improvements in women's health in the United States.